CENTER FOR EVIDENCE-BASED PRACTICE IN THE UNDERSERVED

DESCRIPTION: Although variation in practice is ubiquitous, many studies have documented that underserved populations such as racial and ethnic minorities, women and children, those with lower socioeconomic status, and persons with HIV/AIDS are significantly less likely than others to receive care that is consistent with the best health care evidence. Information technology, informatics processes, and informatics competencies are essential components of evidence based practice. These components support the building of evidence across research protocols and from clinical practice and the application of evidence to practice. The specific aims of the proposal to establish the Center for Evidence based Practice in the Underserved at the Columbia University School of Nursing are to: 1)Establish an Administrative Core structure that utilizes information technology and informatics processes to support collaborative, interdisciplinary research related to evidence based practice in underserved populations; 2)Facilitate the building of evidence for practice in underserved populations through the funding of pilot studies, mentoring of investigators, and other Pilot Core activities; 3)Develop and implement informatics based approaches that enable data aggregation, secondary data use, and building of evidence across CEBP studies; these include translation of research protocols into standardized terminologies, creation of electronic data dictionaries and scoring algorithms for standardized research instruments, and development of a common data repository; 4)Develop the expertise of CEBP investigators in informatics based approaches for targeting and tailoring interventions for underserved populations.